Gene regulatory networks for hair cell regeneration

Project Summary
Hair cells are mechanosensory receptors used in the lateral line systems of aquatic vertebrates and in the
auditory and vestibular organs of all vertebrates. Only hair cells in zebrafish and in other non-mammalian
vertebrates can regenerate completely after being destroyed or damaged by acoustic or chemical exposure.
While in mammals, destroying or damaging hair cells results in permanent impairments to hearing and/or
balance. To understand how to trigger a regenerative response in humans to repair hearing loss due to the
loss of hair cells in the inner ear, it is essential to understand how genes respond to injury and how those
responses are controlled in the genome. My research program is focused on building a complete
understanding of hair cell regeneration by integrating genomics, high throughput genetics, and phenotypic
analysis to investigate gene regulatory networks for hair cell regeneration using the zebrafish as a model
system. We previously performed a targeted ablation of the hair cells in adult zebrafish auditory and vestibular
organs and interrogated the epigenomic and transcriptomic landscape of regenerating adult inner ear sensory
epithelia. Using single-cell analyses, we showed that the support cell population transitions to an intermediate,
“progenitor” cell state that become new hair cells and demonstrate that the cell fate decisions may be driven by
the coordinate regulation and spatial co-binding of Sox and Six transcription factors. By functionally validating a
predicted regeneration responsive enhancer upstream of sox2, we show that precise timing of sox2 expression
is critical for hair cell regeneration in zebrafish. We aim to use these findings to gain insight into the molecular
mechanisms that regulate hair cell regeneration in zebrafish. To do this, we propose to elucidate how Sox and
Six transcription factors control hair cell regeneration. We will examine their spatial and temporal patterns of
expression in the regenerating adult inner ear and conduct loss of function studies to assess their roles in hair
cell regeneration. Based on chromatin accessibility data on regenerating inner ear tissues at single cell
resolution, we have predictions where Sox and Six transcription factors bind. We propose to identify and
characterize their direct targets during regeneration using transgenic reporters, CUT&RUN, and CRISPR/Cas9
disruption. We also have a comprehensive dataset of all the enhancer loci activated during hair cell
regeneration at cellular resolution. A major component of our research program is identifying new regulators of
hair cell regeneration using a mass mutagenesis approach to identify essential enhancers with roles in hair cell
regeneration in vivo. These studies will identify a mechanistic understanding of Sox and Six transcription
factors in regenerating auditory and vestibular epithelia. We predict that these studies will illustrate the gene
regulatory networks involved in hair cell regeneration, which has major implications in discovering therapies to
trigger a regenerative response in humans.

Public health relevance
Narrative Studies on human hearing have illustrated that more than 10% of the American population over 18 years old suffers with some level of hearing loss, with a clear progression in hearing loss as the person ages due to irreversible hair cell damage or loss. The proposed research promises to identify the set of genes and regulatory elements that regulate regeneration of the hair cells, which has major implications in discovering regenerative therapies to trigger a regenerative response in humans.